Effectors of presynaptic cAMP dependent potentiation at mossy fiber synapses

SUMMARY
Synaptic plasticity in the hippocampus is critical to the formation, storage and retrieval of episodic memories.
The separate regions of the hippocampus have evolved to play distinct roles in spatial navigation, contextual
memories, social memories, and our ability to separate patterns or complete patterns to reconstruct partial
memories. In particular the dentate and CA3 regions of the hippocampus are involved in pattern separation
that is vital to the integrity of episodic memories. At the center of this region are the mossy fiber afferents that
make conditional detonator synapses onto CA3 pyramidal neurons, which have a distinct form of presynaptic
cAMP dependent plasticity. Despite the importance of cAMP plasticity to memory formation and retrieval in the
CA3 the exact molecular mechanisms underlying MF LTP have yet to be uncovered. The premise of this
research builds upon our finding that there are at least two downstream cAMP effectors, PKA (protein kinase
A) and Epac2 (exchange protein directly activated by cAMP 2), that contribute to cAMP dependent MF LTP.
Despite these findings it is still not known how signaling by each of these effectors results in elevated release
from MF synapses and, what are the important targets and substrates that are involved in MF LTP.
Here we will use a comprehensive approach with leading edge proteomic, biochemical and
electrophysiological approaches to determine the signaling partners of the cAMP effectors, and uncover the
physiological mechanism of their actions. Thus, in Aim 1 we will take orthogonal approaches to find the
interactors and substrates of PKA and Epac2 and validate these by performing high resolution labeling in situ.
In Aim 2 we will determine the exact physiological mechanism that underlie increases in release of
neurotransmitter at MF synapses using a combined optoactivation-knockout/pharmacological strategy. In the
final Aim we will answer the question of how these different, but convergent, mechanisms are engaged during
naturalistic activity patterns, and whether selective disruption of these effectors impairs the ability of mice to
separate similar patterns that underlie the formation and retrieval of episodic memories.

Public health relevance
PROJECT NARRATIVE The hippocampus is the central brain structure without which we could not navigate our environment or remember recent events. The hippocampal synaptic circuits that mediate information transfer and contribute to the storage and retrieval of memories are therefore crucial to our understanding of memory deficits associated with aging and neurological disorders such as Alzheimer’s disease. In this project we will dissect the mechanisms that contribute to plasticity of a hippocampal synapse and determine how this contributes to specific forms of episodic memory.